Creating a state-level policy data dashboard to facilitate research on reproductive health

The study of state-level Sexual and Reproductive Health (SRH) policies and their impact on health
outcomes is hindered by the absence of a comprehensive, longitudinal database. The existing fragmented and
incomplete data sources limit the field's ability to produce robust research. This project aims to address this
critical gap by creating, optimizing, and disseminating a comprehensive, open-access data dashboard of state
SRH policies spanning from 1973 to 2028 that prioritizes rigorous legal expertise and accessibility for users.
This period crucially captures both historical and contemporary policy changes, starting in 1973 to coincide
with the Roe v. Wade ruling capturing a full six legislative years after the Supreme Court’s Dobbs decision, a
crucial contemporary period of SRH policymaking likely to shape SRH and MCH outcomes for years to come.
Our overarching goal is to facilitate rigorous research on the associations and causal pathways between state
SRH policies and health outcomes. Aim 1 will compile comprehensive state SRH policy data by collecting and
aggregating approximately 90 state-level policies related to the three key domains of abortion, contraception,
and sex education in all 50 states plus the District of Columbia. Rigorous policy surveillance methodology will
be employed to systematically collect and code relevant statutes, regulations, executive orders, case law, and
attorney general opinions. Furthermore, we will engage public health and social science researchers in a
human-centered design process to elicit data requirements and create consistent variables that balance
accuracy with accessibility. Aim 2 seeks to enhance the usability of the data by building a user-friendly
dashboard. This will involve iterative user experience design to optimize functionality and incorporate feedback
from researchers. State-of-the-art data science techniques will be used to create a platform that houses ready-
to-use SRH policy data files and offers multi-policy visualization capabilities. This will enable researchers to
efficiently explore geographic and temporal patterns and policy co-existence. Aim 3 focuses on the
dissemination of the dashboard. We will showcase its utility through peer-reviewed studies that
comprehensively document the history and variability of state policy on abortion, contraception, and sex
education while illustrating its potential uses in future research. We will develop and publish targeted
methodological guidance to facilitate rigorous policy data analysis and support users’ production of high-quality
research. Given the evolving socio-legal landscape with active revisions to SRH policies by states, our
dashboard will provide the definitive source of accurate, research-ready data. It will empower researchers to
conduct the rigorous analyses necessary for evidence-based policymaking, ultimately contributing to the
improvement of SRH and related maternal-child health outcomes in the United States.

Public health relevance
This project aims to facilitate rigorous research on state-level sexual and reproductive health (SRH) policies and their health impact by creating, optimizing, and disseminating an open-access data dashboard of state SRH policies spanning from 1973 to 2028 that integrates legal and substantive expertise and optimizes utility for researchers. By providing accurate and accessible longitudinal data, this initiative supports evidence-based policymaking that can improve SRH and maternal-child health outcomes in the United States.